Creating Physical Objects with 3D Printers to Stimulate Reminiscing for Memory Loss

Abstract Fourteen percent of those 70 and older in U.S. suffer from dementia and over 5 million older Americans are living with Alzheimer's. By 2050, over 16 million will have this disease and will experience impairments in cognitive and intellectual ability, memory, language, reasoning, and judgment that interfere with everyday functioning. Caregivers committed to person-centered dementia care seek non-pharmacological therapies that recognize the meaning of life, authenticity, history and personal preferences of each individual person. Reminiscence therapy (RT) is a form of person-centered dementia care that holds considerable promise. RT involves the discussion of past activities, events and experiences, with another person or small group. This is often assisted by “aids” such as videos, pictures, and life storybooks. Research into the impact of RT has found many benefits including improvements in mood, quality of life, social interaction, cognition, and memory. Benefits for staff include increased knowledge of those in their care and a reduction in caregiver stress. Caregiving staff can use physical objects as triggers or tangible prompts in RT. Objects that have become autobiographical or evocative can be any size. Fortunately, 3D printing technology has advanced to the point where it can be used to produce realistic replicas of autobiographical objects at a relatively low cost. This Phase 2 project has two aims. One, to design and implement an operational model for identifying, producing, and deploying 3D objects for RT while managing object fidelity and cost. A successful model such as this will be essential for commercialization, ensuring quality and cost control. Second, we will conduct a randomized control field evaluation of RT using 3D-printed objects. We have two hypotheses. 1) Over a regular program of RT consisting of 16 sessions, the personal object replicas produced by 3D printing will be more effective in stimulating autobiographical memory than other stimuli to reminiscence, and will result in improvements in memory, mood, social interaction, and quality of life. 2) A dosage of 16 sessions of RT using 3D objects will be more effective than a dosage of 8 sessions using 3D objects plus 8 sessions of RT using other stimuli.

Public health relevance
Project Narrative In 2013 an estimated 5 million people age 65 and older had Alzheimer's disease. Longer life spans and aging baby boomers will cause this number to grow rapidly. More than 50% of residents in assisted living and nursing homes have some form of dementia or cognitive impairment and the number is increasing every day. As a form of person-centered, non-pharmacological dementia care, Reminiscence Therapy (RT) holds considerable promise. Improvements in mood, quality of life, social interaction, cognition, memory and a reduction in caregiver stress have been noted. This project will develop an operational model for identifying and producing 3D personal objects using 3D printing technology, and deploying them for use in RT. The research also will evaluate the effectiveness of using 3D-printed objects in RT compared to other types of memory stimuli. This novel approach to the “personalization” of reminiscence therapy will result in better mental and physical health outcomes for individuals with dementia and the quality of the relationships they have with direct care staff will improve as well. .